Outreach Core

PROJECT SUMMARY/ ABSTRACT – OUTREACH CORE
The Cancer Research and Education to Advance HealTh Equity (CREATE) Partnership’s geographic area is
composed of San Diego and Imperial Counties, the two U.S.-Mexico border counties in California which
include ~3.5 million residents. This region is a majority-minority area, with extensive cultural, linguistic, and
racial/ethnic diversity. Disparities in cancer risk factors, screening, treatment and survivorship continue to
persist nationally and within the Partnership’s region, particularly among underserved groups. Generally,
medically underserved individuals are diagnosed with cancer at a later stage and have poorer survival
compared to individuals who are more affluent. Reducing these cancer disparities requires capacity
development for evidence-based practice and community-engaged research and practice dissemination. There
is also a need for greater engagement and training of researchers from under-represented backgrounds to
collaborate with community organizations that serve this population. Further, communities rarely have
opportunities to develop research programs and implement evidence-based practices in collaboration with
expert clinicians and researchers. Using innovative approaches that are integrated into all Partnership
components, the Outreach Core addresses these gaps through its overarching goal: To integrate community
engagement principles into all CREATE Partnership activities. To accomplish this, the Outreach Core will
adopt the Community-to-Bench model, which provides an intentional effort to ensure community engagement
and bi-directional dialogue. The following Specific Aims are proposed: 1) Advance cancer health equity by
facilitating and supporting catchment area-relevant research and community-engaged research including but
not limited to Partnership-sponsored research projects; 2) Provide support to community health centers for
screening, early detection, linkage to care and referral pathways; 3) Foster community engagement by
conducting needs assessments, disseminating evidence-based practices and resources and implementing
educational and outreach activities; and 4) Contribute to the Partnership’s educational mission by providing
educational opportunities to undergraduate, graduate and medical students, as well as early-stage
investigators in areas of community-engaged research and cancer disparities. Working closely with the
Community Advisory Board, the OC will build upon existing community partnerships to further expand the
Partnership’s outreach activities with underserved communities and to support research in catchment area
priority cancers. To conduct this work, the Core has assembled a multidisciplinary team with expertise in
cancer disparities research, prevention, multilevel interventions, and community health system interventions.
The Core’s collaborative approach is responsive to community needs and will improve cancer health equity in
the Partnership’s region and beyond.